Modeling and manipulating social percepts in individuals

PROJECT SUMMARY
Biases in if and how social interactions are perceived are a hallmark symptom of most major mental illnesses
(e.g., people with autism tend to under-perceive social interactions, people with paranoid schizophrenia tend to
over-perceive social interactions, and people with depression tend to perceive social interactions in a negative
light). These biases likely reflect the extreme end of a continuum that exists in the normative population,
suggesting that characterizing individual differences in social-perceptual styles is critical to furthering our
understanding of disease. That humans are primed to perceive social interactions even in stripped-down,
unlifelike stimuli (e.g., animations of geometric shapes) is a phenomenon that has long been recognized and
exploited to study social cognition in both normative and patient populations. However, when it comes to these
basic stimuli, while we may have the intuition that we “know it when we see it”, we do not understand what it is
about stimuli deemed social that makes them social—in other words, which specific visual features are
required, and in what doses. Furthermore, because task paradigms are often a simple binary choice (i.e.,
‘social’ or ‘random’), we do not understand heterogeneity across individuals in terms of their thresholds for
deciding if a given stimulus represents a social interaction, and if so, what kind of social interaction (i.e.,
positive or negative). A critical step toward understanding and correcting biased social cognition in mental
illness is to define the fundamental sensory features of basic social interactions, and determine how and why
different people compute differently on these features to give rise to different social percepts. This will open the
door to interventions that can prevent an individual from going down a biased path. In this project, we will
establish a social stimulus class for which we have precise, parametric control over low-level visual features.
This will allow us to construct individual “social tuning curves” for various types of social interactions and
determine how variability in these tuning curves relates to trait phenotypes. Combining these stimuli with
simultaneous neuroimaging (fMRI) and eye-tracking will shed light on where in the processing hierarchy
percepts diverge within and across individuals, and allow us to test the hypothesis that social percepts emerge
earlier in the cortical hierarchy than previously thought. This would indicate that idiosyncratic social cognition is
more closely linked to automatic, sensory-driven processes than controlled reflection, a distinction that is
important for informing diagnostic and interventional tools. Finally, within a set of densely sampled individuals,
we will directly test causality between stimulus features, brain activity, and percepts using real-time fMRI to
implicitly steer individuals toward a given percept based on pre-stimulus brain activity. The outcome of the
proposed research will be a causal model of how stimulus features and brain dynamics interact to give rise to a
given social percept within a given individual. This model will provide testable hypotheses regarding targeted
therapies to normalize biased cognition in mental illnesses.

Public health relevance
PROJECT NARRATIVE Disrupted social cognition is a risk factor, core symptom, and maintenance factor for most major mental illnesses, including autism, schizophrenia, and depression. At their core, these disruptions involve biases in if and how social information is perceived, a process that also varies across individuals in the normative population. The proposed research will determine the behavioral and neural mechanisms that underlie how different individuals can perceive the same social information in different ways, and identify novel intervention and treatment targets for biased social cognition in mental illness.